Mechanisms of robustness in organogenesis (Equipment Supplement 2023)

Project Summary/Abstract
Development is remarkably reproducible, generally producing the same organ with invariant size, shape,
structure, and function in each individual. Robustness is the ability of cellular systems to adjust and develop
the correct size and shape organs in the face of stochastic fluctuations, and environmental and genetic
variations. In the absence of robustness, these perturbations would cause large variations in organ size and
shape. The mechanisms proposed to create robustness include negative feedback loops, redundancy in
regulatory networks, intercellular signaling to coordinate cell behaviors, spatiotemporal averaging of variability,
and mechanical signaling, all of which function at the systems level and are repeatedly observed in
multicellular organisms including humans. To determine how robustness emerges, we identified mutants with
enhanced variability in organ size or shape (vos), thus disrupting robustness. Our Arabidopsis thaliana sepal
(outermost floral organ) system is uniquely well suited for these studies because each plant produces more
than 100 sepals, allowing statistical analysis of organ robustness in a single individual, which cannot be done
in most other systems. Our goal is to use these vos mutants in combination with an innovative quantitative
biology approach combining live imaging of growing sepals, image processing to quantify growth,
computational modeling, biomechanical tests, molecular genetics, and genomics to elucidate mechanisms
generating robustness. We hypothesize that mechanical signaling and coordination of growth may be
particularly important for robustness of organ shape and size. (Aim 1) First, we will elucidate the role of
mechanical signaling in spatiotemporal averaging to produce robust organs. Based on computational
modeling, we hypothesize appropriate mechanical signaling is required for spatiotemporal averaging of cellular
growth variability to produce robust organs. We will test this hypothesis using mutants that alter mechanical
signaling in conjunction with the vos1 mutant, which inhibits spatiotemporal averaging. (Aim 2) Second, we will
determine the mechanisms that synchronize organ initiation and how they contribute to robustness of
organ size. vos2 mutants exhibit variable sepal size and irregular timing of sepal primordia initiation. We will
test the hypothesis that variable organ sizes result from a loss of robustness in the timing of organ initiation
through examining biomechanics and hormone signaling, both of which contribute to primordium initiation.
(Aim 3) Third, we will determine how coordination of growth across the three dimensions of the organ
contributes to robustness in shape. vos3 mutants exhibit variable sepal shapes; we hypothesize this results
from perturbed coordination of growth between tissue layers leading to mechanical buckling of the outer sepal
surface. We will use computational modeling to predict differences in growth rate and mechanics that can
cause mechanical buckling and test these in vos3. Together, these aims will reveal mechanisms and principles
generating robustness of organ size and shape, which underlie human development.

Public health relevance
Project Narrative The development of all complex multicellular organisms, from plants to humans, is robust in that it reproducibly produces organs of the correct size, shape, and function despite the inevitable physiological and environmental stresses of everyday life. This project takes a quantitative biology strategy combining genetics, imaging, genomics, computational analysis, modeling, and micromechanics to elucidate mechanisms producing robust organ size and shape. Through acquiring a deep understanding of the fundamental mechanisms and principles through which robustness is generated, we can gain insights that will help us better address birth defects wherein this reproducibility breaks down.